Retrospective Magnetic Resonance Image Harmonization for Robust Federated Learning

Project Summary
Deep learning algorithms have revolutionized the field of medical image analysis with their ability to automatically
extract information without the need for handcrafted features. These algorithms have been shown to be
particularly effective for image segmentation (identifying regions of interest) in well-curated datasets. However,
deep learning can perform suboptimally when applied to input data acquired differently from the training data.
This issue of “out of distribution data” or “domain shift” hinders accurate and robust performance when applied
to magnetic resonance (MR) images given the diversity of both subject populations and MR acquisition protocols.
The appearance of MR images is notoriously sensitive to both hardware differences and software differences
and as a result, routine use of deep learning has proven to be extremely challenging in clinical neuroimaging. In
this project, we propose to surmount the challenges of domain shift in medical images by combining two
approaches: federated learning (FL) and harmonization. To focus our work on this problem, we will specifically
work with MR data from people with multiple sclerosis (MS), an inflammatory disease of the central nervous
system and a leading cause of neurological disability in younger adults. Because reduction or stabilization of
white matter lesion burden is one of the goals of MS therapy, there is strong interest in establishing accurate and
reliable white matter lesion quantification from MR images. Machine learning would seem to offer a viable
solution, but despite decades of research, there is no method for automated lesion segmentation that can be
robustly applied across data from different research and clinical sites. One approach is to expand the amount of
training using FL, which builds a deep learning model across multiple institutions without requiring sharing of
patient data. This bypasses the legal and regulatory restrictions associated with sharing patient data, while
enabling training with a much richer and more diversified dataset. The advantage of working with larger training
data sets, however, brings the challenge of dealing not only with heterogeneous MR acquisitions but also
inconsistent labeling protocols from different sites. Our team has recently developed state-of-the-art
retrospective image harmonization techniques that mitigate variations in structural MRI contrast, spatial
resolution, and even artifacts. We will perform three aims: 1) Augment and optimize image harmonization
algorithms using FL; 2) Develop and validate an integrated approach to FL for harmonized lesion segmentation;
3) Implement and distribute an FL platform for MS lesion segmentation. Harmonization provides a task agnostic
solution to addressing domain shift in MR imaging and will maximize the utility of training data that may be
discrepant with respect to both acquisition properties and labeling protocols. The proposed FL framework will
facilitate collaboration across institutions to provide a novel, vastly improved framework for shared image
analysis algorithm development, leading to more robust measurements and more reproducible science.

Public health relevance
Project Narrative Machine learning algorithms can perform poorly when trying to analyze magnetic resonance imaging data because their appearance is highly variable and often different from the data that was used to train the algorithms. We will develop methods to make the algorithms more robust by training them with larger amounts of data from multiple institutions while simultaneously reducing the variation in their appearance. We will demonstrate the effectiveness of our approach by building algorithms to automatically find lesions in magnetic resonance brain images from people with multiple sclerosis.